METABOLISM/BODY COMPOSITION IN SEDENTARY PARAPLEGICS

This study evaluates the basal metabolic rates, peak oxygen consumption and the total body and regional body composition in physically trained versus sedentary spinal cord injury volunteers.